CORRELATION BETWEEN INTRACELLULAR IONIC CONCENTRATIONS AND BLOOD PRESSURE

The purpose of this study is to examine the connection between intracellular ion concentrations (which have been correlated with essential hypertension) and blood pressure in normal healthy adults.